Colorado Department of Agriculture FY26 AFRPS Maintenance Application

Research Strategy
Standard 1
● Rulemaking to adopt Recordkeeping requirements, GMPs, and PFLM with legal
review
● Regulatory Review to update authorities granted in rulemaking
Standard 2
● Begin development of develop GMP Inspection Training
● Begin development of label training to include PFLM
● Add contract inspection training to curriculum
Standard 3
● Begin development of GMP Inspection SOP
● Begin development of inspectional PFLM label review
● Develop Contract audit SOP
● Update complaint system SOP
Standard 4
● Develop/adopt Contract Audit forms
● Perform ﬁeld and desk audits
Standard 6
● Enforcement review
Standard 7
● Develop outreach materials
Standard 9
● Continue development and utilization of document control system

Public health relevance
Colorado Research Strategy Narrative In addition to maintaining implementation of the Animal Food Regulatory Standards, The CDA Feed Program will undertake rulemaking for the Commercial Feed Rules and the Pet Food Rules. Goals of this rulemaking will be to incorporate 21CFR507 Subpart B as well as recordkeeping requirements. Currently, a CDA feed inspection consists of collecting samples, verifying registration, and reviewing animal feed labels. By incorporating the requirements of 21CFR507 Subpart B we will be able to begin GMP inspections under state authority. Recordkeeping requirements will also be adopted in order to facilitate traceback/traceforward investigations as needed. For our Pet Food Rules, we will also be incorporating new labeling requirements developed in accordance with the Pet Food Label Modernization Act. Both rules will be reviewed by staff from the Colorado Attorney General’s office as part of the rulemakings. Our submitted budget includes those costs in support of Standard 1. Standard 2 will require new training to be developed to address the new authorities for GMP inspections that will be added to the rulemakings, as well as training to incorporate new pet food label requirements. Additionally, training will need to be incorporated for Colorado to begin auditing of contract inspections. Standard 3 will require the development of new inspection standards operating procedures to support the new GMP inspectional authorities that will be added in these rulemakings. A new complaint system and SOP will also be developed. Under Standard 8, the CDA Feed Program plans to purchase new feed sampling probes as well as copies of the 2026 AAFCO official publication for inspectors and staff. For other Standards not listed in this narrative, implementation status will be maintained.